CRCNS: Repurposing Transformers to Characterize Gut Microbiome & Aging Brain Axis

For debilitating neurodegenerative diseases such as Alzheimer’s disease (AD), some drugs have been
approved but only offer a modest attenuation of cognitive decline. There is a need to better understand the
role of modifiable risk factors which could decrease the risk of AD and other types of dementia. The human
gut microbiome–comprising of microbes and their associated genes–shows differences in composition
between healthy individuals and those with AD dementia, and based on recent studies appears to be a
promising modifiable risk factor. Despite encouraging findings, large gaps remain regarding our knowledge
of the gut microbiome’s relationship with the aging brain and dementia pathology measured via
neuroimaging, fluid biomarkers, and cognitive assessments. Fortunately, datasets that can enable this
analysis are growing in terms of sample sizes, making a comprehensive machine-learning based
investigation of these associations timely and potentially highly rewarding. To this end, our team proposes
to make use of and extend contemporary developments in Transformer-based models that power
advancements in large language model (LLM) technologies, and repurpose them into specialized models
for these analyses for multi-modal datasets. The key components of this project include the following aims.
Aim 1: We will design special Transformer-based models that will be trained using microbiome data via
attaching novel trainable modules. These repurposed models will enable analysis of associations between
gut microbiome composition and brain health in dementia. Aim 2: Our models will be extended to handle
3D neuroimaging data with an eye on computational efficiency. The models will be rigorously evaluated on
large imaging datasets as well as on multi-modal datasets. Their performance/generalization behavior will
be profiled. Aim 3: The models will be used to study the relationship between the gut microbiome and the
brain, anchored by eight specific scientific hypotheses. Pretrained models and software tools will be
disseminated to the community. Significance: This project will yield sophisticated methods for multimodal
analysis of microbiome, brain imaging and clinical/cognitive data for aging and Alzheimer’s disease. These
tools will be disseminated and can be used to investigate a variety of scientific hypotheses to determine
novel relationships between the microbiome and the brain. This in turn is expected to open new avenues
for preventing and treating neurodegenerative disease and improve the health and well-being of aging
Americans.

Public health relevance
RELEVANCE (See instructions): Alzheimer's disease (AD) is the 7th leading cause of death in the US and approaches for reducing the number of people affected by dementia are needed. Studies show that the gut microbiome may play a role in pathogenesis of AD. This project will use machine learning to understand the role of the gut microbiome in AD development. Insights and software from this project are expected to inform the development of new therapies for AD and improve the well-being of aging Americans.